Identification of a cellular immune signature unique to clinically-significant villitis of unknown etiology

Project Summary/Abstract
Fetal growth restriction (FGR), defined by a fetus failing to fulfill its growth potential, is a common complication
of pregnancy, associated with several adverse neonatal outcomes, including stillbirth. Villitis of unknown
etiology (VUE) is a chronic inflammatory lesion of placental villi, associated with late-onset FGR (onset after 34
weeks gestation). VUE, defined by infiltration of chorionic villi with maternal T cells and an expansion of fetal-
derived macrophages (so-called Hofbauer cells), is most common at term and considered to be a form of
allograft rejection. Unlike infectious villitis, VUE lesions have a risk of recurrence in subsequent pregnancies
with the same partner, leading to worsening FGR and even stillbirth. However, based on histopathologic
features alone, it is difficult to identify clinically-significant VUE (e.g., those that are causative of FGR and thus
highly likely to recur): there is much disagreement about criteria for grading this lesion, with published studies
and our own preliminary data from over 3,500 placentas, showing no difference in FGR between low- and high-
grade VUE. Over the past ~15 years, several studies have advanced our knowledge of this lesion, including
identification of regulatory T cells, activation of the JAK-STAT pathway in syncytiotrophoblast (STB), and
upregulation of chemokines CXCL9 and CXCL13, in regions of VUE, pointing to chemoattractant-driven
immune cell infiltration in the development of this lesion. Furthermore, comparison of immune checkpoint
pathways in infectious villitis vs. VUE have pointed to a loss of immune tolerance only in the latter form of this
lesion. Most recently, application of spatial ‘omics technologies to this lesion has led to identification of T cells
with an activated memory phenotype, and Hofbauer cells with upregulated PD-L1 checkpoint receptors.
However, these latter studies have involved evaluation of a small number of cases, still leaving a rather
incomplete understanding of VUE pathophysiology, particularly with respect to distinguishing between
clinically-significant, rather than benign, VUE. We therefore propose to apply high-throughput mass
cytometry to identify cellular signature(s) specific to VUE associated with FGR, e.g., cases with the
highest potential for recurrence. We hypothesize that SGA-associated VUE is characterized by a distinct
cellular profile, comprised of chronic immune responses and trophoblast and/or endothelial damage, and
propose to test this in a cohort of previously-banked placental tissues (Aim 1) and prospectively-banked
placental immune cell isolates (Aim 2), using state-of-the-art mass cytometry. Successful completion of this
proposal will begin to unravel the detailed pathophysiology of VUE, identify cellular signatures which
distinguish clinically-significant lesions associated with FGR, and lay the foundation for diagnostic
biomarker discovery for late-onset FGR, which is often associated with stillbirth.

Public health relevance
Project Narrative Fetal growth restriction (FGR) is a common complication of pregnancy, associated with adverse neonatal outcomes, including stillbirth. Villitis of unknown etiology (VUE) is a chronic inflammatory lesion of the placenta, associated with late-onset FGR, with a risk of recurrence in subsequent pregnancies. This project will use placental tissues and immune cell isolates from pregnancies complicated by VUE, with or without FGR, to identify cellular signatures associated with clinically-significant (i.e., FGR-associated) VUE.